Multispectral Sensor for Chemical Composition Analysis of Ultrafine Aerosols in Air Quality Assessment

Project Summary
We propose a diversity supplement to support the research of a Graduate Student under an existing parent
grant which aims to develop and validate a novel platform technology that combines the collection and chemical
analysis of ultrafine particles using an in-situ multispectral technique. The sample, collected directly onto the
analysis substrate, is analyzed via excitation-emission matrix (EEM) spectroscopy. This approach will be
validated against laboratory combustion-generated aerosols, such as diesel exhaust, wood smoke, tobacco
smoke, and against a mixture of environmental pollutants. Within the respiratory tract, particle size determines
the region of deposition and tissue uptake; the chemistry of the particle also affects solubility and determines the
potential for biochemical reaction with tissues and cells. There is a growing awareness that exposure scenarios
are very complex, consisting of time-varying concentrations and chemical composition over a broad range of
particle sizes. Long-term exposure to air pollution has also been linked to increased mortality rates for infectious
diseases, including COVID-19. The proposed research addresses the need for improved personal exposure
assessment and characterization of ultrafine particles in the environment. Low-cost, miniaturized exposure
monitoring devices can shed insight into the relationships between exposure to pollutants and health impact.
Source apportioned measurements of PM concentration with high temporal and spatial resolution can facilitate
the implementation of optimal air pollution mitigation strategies. The anticipated outcome of this project is the
development of a miniaturized spectroscopic sensor that provides an analysis of the chemical composition of
combustion-generated ultrafine particles, which both reflects the particle sources and determines their toxic
potential. The machine-learning algorithms will enable the deconvolution of the complex spectra and
identification of the PM source from the EEM analysis. The broader applications of the technology are
environmental and regulatory monitoring, personal exposure assessment for the consumer market, and
epidemiological studies.

Public health relevance
Project Narrative The current system testing for ultrafine particulate matter derived from combustion sources and engineered nanomaterials is currently too large to be worn by a user. The project needs support to miniaturize the current system into an efficient wearable sensor for these materials. This diversity supplement addresses the need for support to advance the viability of the new sensor system with the addition of a new team member.